Pipeline to Graduate Education and Careers in Behavioral and Social Science Research for URM Undergraduates: Addressing HIV in Sexual and Gender Minority Communities

PROJECT SUMMARY
Sexual and gender minority (SGM) people and communities account for the vast majority of HIV cases in the
United States, with Black and Latinx people being disproportionately affected. Unfortunately these communities
also experience a host of negative societal factors. Therefore, the next generation of HIV behavioral and social
science researchers must have cutting edge knowledge of the complex factors that influence HIV prevention
and care within SGM communities, and possess the interdisciplinary research skills and experiences needed
to develop innovative and effective approaches to ending the HIV epidemic. This administrative supplement
will greatly enhance the impact of our funded NIMH Research Education Mentoring Program for HIV/AIDS
Researchers (R25), the Student Opportunities for AIDS/HIV Research (SOAR). It is a multi-component theory-
based 2-year long research-intensive program for University of Michigan undergraduate students who
participate in faculty mentored research experiences and other evidence-based programs and activities during
their junior and senior years. They remain connected to SOAR after graduation and into their graduate
programs through our interactive SOAR website, and provide mentoring and role-modeling for current
students. Recruitment of students focuses on individuals from NIH-designated groups that are under-
represented in the biomedical, clinical, behavioral and social sciences (URM: NOT-OD-20-031). Given the
program's thematic focus on HIV-centered behavioral and social science research priorities within SGM
communities, we also encourage participation from URM students who identify as SGM (NOT-OD-19-139).
SOAR is grounded in the expanded Social Cognitive Career Theory (e-SCCT); patterned after the evidence-
based U.S. Department of Education funded Ronald E. McNair Post-baccalaureate Achievement Program; and
incorporates elements of the evidence-based research mentoring program Entering Mentoring and the
evidence-based research mentee program Entering Research. SOAR was designed to advance the priorities
in FY 2021–2025 NIH Strategic Plan for HIV and HIV-Related Research, the NIMH Division of AIDS Research
Priority Areas, and Ending the HIV Epidemic: A Plan for America. We are providing the two-year SOAR
program to four cohorts of undergraduate students. Specific Aims are as follows: (1) To fully develop and
deliver a multi-component theory-based HIV research education mentoring program for URM undergraduate
students who will participate in two consecutive years of faculty-mentored research experiences and other
evidence-based programs and activities during their junior and senior years. (2) To guide URM undergraduate
students into career trajectories as independent researchers in the mental health of HIV/AIDS. (3) To provide
evidence-based culturally aware mentor training for faculty, staff, graduate students, and undergraduate
students as peer mentors themselves.

Public health relevance
PROJECT NARRATIVE This administrative supplement will greatly enhance the impact of the Student Opportunities for AIDS/HIV Research (SOAR) program, which is a multi-component theory-based two-year long research education and mentoring program for University of Michigan undergraduate students from NIH-designated groups that are underrepresented in the biomedical, clinical, behavioral and social sciences. Given the program's thematic focus on HIV-centered behavioral and social science research priorities within sexual and gender minority (SGM) communities, we encourage participation from URM students who identify as SGM. SOAR is grounded in the expanded Social Cognitive Career Theory; patterned after the evidence-based U.S. Department of Education funded McNair Post-baccalaureate Achievement Program; incorporates elements of the evidence- based research mentoring program Entering Mentoring and the evidence-based research mentee program Entering Research; and allows for two years of intensive faculty-mentored research experiences for undergraduate students interested in pursuing doctoral education leading to a research career in the mental health of HIV/AIDS.